The role of astrocytes in prion strain susceptibility

PROJECT SUMMARY AND ABSTRACT:
Prion diseases are fatal neurodegenerative diseases in which the conversion of the cell-surface protein (PrPC)
to its infectious conformer (PrPSc) leads to neuronal death. Distinct conformational variations in PrPSc result in
prion strains, which can display widely different symptoms, cell type localization, and PrPSc deposition patterns
in the brain. Single cell RNAseq analysis over the course of disease has revealed neuronal transcriptomic
changes occur only in the final stages of the disease process, after symptoms have appeared, shortly before
death. However, most preclinical transcriptomic alterations were found astrocytes, suggesting a key role for non-
neuronal cells in prion pathogenesis. Astrocytes have comparable levels of PrPC to neurons and are infectible
with prions. They can also phagocytose PrPSc and secrete inflammatory factors in response. The recent
discovery of transcriptomic heterogeneity of astrocytes between brain regions suggests that astrocytes may
contribute to the distinct regional deposition of PrPSc associated with different strains. My goal is to identify what
astrocytic cellular processes impact prion disease and how astrocyte regional identity affects prion strain
susceptibility. There has been limited previous research investigating the cellular mechanisms underlying
astrocyte infection and its impact of astrocyte reactivity and processing of PrPSc. To address these gaps, this
proposal uses an in vitro infection model of primary astrocytes, enabling the characterization of initial infection
stages and offering the ability to understand the process at a mechanistic level. I hypothesize regionally distinct
astrocytes differ in their susceptibility to prion strains because of variations in their uptake, localization, and
propagation. In AIM 1, I will characterize the localization and processing of PrPSc by astrocytes and determine
whether prion exposure is sufficient for activation. In AIM 2, I will characterize the prion strain susceptibility of
astrocytes isolated from different brain regions and infected in culture, and by infection of organotypic brain
slices. Accomplishing these goals will offer a more detailed mechanistic understanding of the impact of infected
astrocytes in prion diseases, and beyond its contribution to the prion field, this research will shed light on the role
of astrocytes in other neurodegenerative conditions.

Public health relevance
PROJECT NARRATIVE: We do not understand how the prion protein strains, although very similar in structure act so differently in the brain. This project will help to understand prion strain susceptibility by examining astrocytes, a cell that is infectible with prions and whose regional identity may alter the way prions are propagated and processed. Our results will also have an impact for the neurodegenerative field by understanding the cellular biology mechanisms of astrocytes and how this affects disease severity.